Cellular and Molecular Mechanisms of GBM Infiltration

Summary
Glioblastoma (GBM) is the most common and deadly form of primary brain tumor in adults. One feature of
GBM that makes it exceedingly difficult to cure is its diffuse infiltration throughout the brain, as treatment,
including surgical resection of the primary tumor invariably results in recurrence, often remote from the site of
the original tumor. This clinical feature illustrates a key knowledge gap in GBM biology, as the cellular and
molecular mechanisms that drive the migration of tumor cells in the brain remain poorly defined. Recent
studies have shown that GBM progression is tightly linked to neuronal activity and our preliminary studies show
that increased neuronal activity stimulates migration of GBM cells towards hyperactive neurons in the
contralateral hemisphere. To decipher the molecular mechanisms driving activity-dependent, GBM infiltration,
we performed transcriptomic analysis of these tumors, finding enrichment of axon guidance genes and drastic
alterations in immune-related signatures. Functional studies with the axon guidance gene cohort revealed that
overexpression of EphA6, EphA7, or Sema4F in mouse GBM promoted infiltration of tumor cells and
decreased survival of tumor bearing mice. Similarly, we found decreased CD8-Tcells in response to activity-
driven infiltration and preliminary studies suggest that loss of these populations enhances malignant
progression.
Based on the strength of these preliminary studies we propose three specific aims that seek to uncover
the cellular and molecular mechanisms driving GBM infiltration. In aim 1, we will manipulate the activity of
subsets of neurons in order to dissect which sub-types of neurons promote GBM infiltration. In aim2, we will
determine how EphA6, EphA7, and Sema4F contribute to GBM infiltration and pathophysiology. In aim3, we
will determine how neuronal activity influences immune responses, while determining how CD8 T-cells
contribute to GBM infiltration. Together, these aims will uncover which neuronal populations promote GBM
infiltration, while revealing new roles for axon guidance genes and chemokine receptors in tumor
pathophysiology.

Public health relevance
Narrative The focal point of this project is to decode the cellular and molecular mechanisms that drive infiltration of glioblastoma (GBM), which is a major cause of recurrence and contributes to the high mortality rate of this disease. We propose to uncover how the activity of subsets of neurons contributes GBM infiltration, while also examining the roles of axon guidance genes in GBM infiltration. These studies will reveal new cellular and molecular mechanisms that control the infiltration and invasion of GBM that are likely to be applicable to other forms of brain tumors and also other types of tumors that metastasize to the brain.